Effect of infant antibiotics on the development of the early-life airway and gut microbiome and risk of childhood asthma

PROJECT SUMMARY
The use of antibiotics in the first year of life has been recognized as a strong, consistent, and modifiable risk
factor for the development of asthma in childhood in numerous individual studies. However, a critical window
during which infant antibiotic exposure could have a greater effect on childhood asthma risk has yet to be
identified. Furthermore, whereas the results of some studies indicate that this association is likely due to
changes in the human microbiome, these studies have used techniques that are unable to accurately identify
relevant bacterial species or their function, which is critical to design interventions to prevent the long-term
detrimental effects of infant antibiotic exposure. To address these multiple knowledge gaps, the goals of this
proposal are 1) to determine the age when infants are most susceptible to the harmful consequences of
antibiotics on childhood asthma risk, 2) to examine microbial pathways through which infant antibiotic exposure
could lead to childhood asthma, and 3) to identify early-life upper respiratory tract (URT) and gut bacterial
species, patterns, and/or products that could increase the resilience of these 2 microbial communities and be
protective for childhood asthma onset after infant antibiotic exposure. To achieve these goals, we propose the
following specific aims: 1) to test the hypothesis that the age of infant antibiotic exposure is inversely
associated with childhood asthma risk (aim 1), 2) to test the hypothesis that infant antibiotic exposure is
associated with changes in the taxonomic and functional profiles of the URT and gut microbiome throughout
the first year of life (aim 2A), and that these changes mediate the association of infant antibiotic exposure with
childhood asthma risk (aim 2B), and 3) to test the hypothesis that, among infants exposed to antibiotics,
specific taxonomic and functional profiles of the early-life URT and gut microbiome are associated with
childhood asthma risk. To accomplish our goals in an effective and cost-efficient manner, we will 1) capitalize
on the strengths of our prospective birth cohorts with distinct longitudinal study designs, comprehensive
information on infant antibiotic exposure, and serial sampling of the URT and gut, 2) leverage the cutting-edge
laboratory and bioinformatic pipelines that we have assembled for our numerous prior studies of the human
microbiome, and 3) build upon an ongoing and successful collaboration between experts in the field. Our
proposal is a stepping stone to address a critical and unmet need: how to protect children from the long-term
detrimental effects of infant antibiotic exposure. By identifying a critical window of opportunity to intervene, the
microbial pathways to target, and candidate probiotics and/or bacterial products, the ultimate goal of the
planned studies is to inform the design of microbiome-based therapeutics that can help deliver antibiotics
safely during early life and reduce the burden of childhood asthma.

Public health relevance
PROJECT NARRATIVE The use of antibiotics in the first year of life has been recognized as a strong, consistent, and modifiable risk factor for the development of asthma in childhood in numerous individual studies and several meta-analyses. The goals of this proposal are 1) to determine the age when infants are most susceptible to the harmful consequences of antibiotics on childhood asthma risk, 2) to examine microbial pathways through which infant antibiotic exposure could lead to childhood asthma, and 3) to identify early-life upper respiratory tract and gut bacterial species, patterns, and/or products that could increase the resilience of these 2 microbial communities and be protective for childhood asthma onset after infant antibiotic exposure. By identifying a critical window of opportunity to intervene, the microbial pathways to target, and candidate probiotics and/or bacterial products, the ultimate goal of the planned studies is to inform the design of microbiome-based therapeutics that can help deliver antibiotics safely during early life and reduce the burden of childhood asthma.